P&F Program

The Pilot and Feasibility (P&F) Program of the Diabetes Research Center at the University of Washington
promotes the development of new and innovative research directed at basic biomedical, clinical, behavioral
and translational aspects of diabetes and its complications. The specific objectives of the Program are to: (1)
Provide initial research support for promising junior faculty who have not yet had independent peer-reviewed
NIH funding; (2) Provide pilot funding for established faculty entering the field of diabetes research for the first
time; (3) Support pilot projects by established diabetes investigators proposing to pursue high impact/high risk
projects or a novel direction in their diabetes related research; (4) Provide pilot funding to underrepresented
minorities and support pilot projects that focus on diabetes and related disorders in underrepresented
minorities; and (5) Foster mentored training in research related to diabetes by offering postdoctoral and
graduate fellowships. The P&F Program will award annually $250,000 of the Center’s NIDDK direct funds (a
minimum of 25%) for P&F research projects. In addition, funds provided by the University are used to support
new investigator research, training of postdoctoral fellows and graduate students, and service grants for junior
investigators to use the Center’s resources. Applications are peer-reviewed by external and internal reviewers
and the Center’s Executive Committee, with awards being made based on scientific merit and qualifications of
the applicant, including the potential for subsequent external peer-reviewed funding. During the last decade
(two funding cycles), NIDDK funds to the Diabetes Research Center at the University of Washington supported
26 P&F awards. The majority of awardees were junior faculty, with four being underrepresented minorities and
11 females. Of the 26 P&F investigators funded over the last ten years, 25 remain active in research related to
diabetes, obesity and related disorders (96% success). Thus, the P&F Program continues to be a highly
successful component of the Diabetes Research Center that utilizes funds provided by NIDDK and the
University of Washington to support new and innovative research in the area of diabetes, obesity and related
disorders, and in this manner also fosters the career development of junior investigators.